MEDIC-MicroED Imaging Center at UCLA

MEDIC – MicroED Imaging Center at UCLA
PROJECT SUMMARY
The MicroED Imaging Center (MEDIC) at UCLA is a current Biomedical Technology Research Resource center
devoted to the advancement and dissemination of the Microcrystal Electron Diffraction (MicroED) method.
MicroED facilitates the determination of new previously unattainable structures at atomic resolution from
vanishingly small crystals. MicroED exploits the strong interaction between electrons and nano-scale three-
dimensional crystals and takes advantage of emerging cryo-EM instrumentation coupled to established
crystallographic methods. We pioneered MicroED and established the current highly successful and innovative
center in 2020. Since then, MEDIC trained over 1000 individuals, led to the establishment of robust pipelines
and methods for sample preparation, data collection and reduction; provided sorely needed software to the
community (which was downloaded >15000 times) and disseminated results in social media, workshops, peer
reviewed papers and commentaries that collectively have been downloaded >83,000 times. MEDIC was heavily
involved in dissemination of MicroED and training the next generation of practitioners through our highly
successful community engagement programs. MEDIC collaborated with key technology partners to develop
MicroED systems and currently two leading manufacturers are offering MicroED solutions based on the
technologies we developed.
We are proposing to transition the highly innovative and impactful MEDIC center to a Biomedical Optimization
and Dissemination (BTOD) center. We outline comprehensive plans for MEDIC administration, three Technology
Optimization and Dissemination projects (TOPs), applications through center selected Driving Biomedical
Projects (DBPs), and a comprehensive Community Engagement effort, including several technology
partnerships. The TOPs are focused on (1) Enhancing macromolecular MicroED through optimization of sample
preparation methods, (2) Optimizing MicroED applications in chemical crystallography and drug discovery, and
(3) transforming MicroED into a high throughput method through optimized automated data collection and
processing procedures. These TOPs will directly interact with the carefully selected DBPs, which present unique
and challenging samples that are impossible to study with any other approach. These DBPs will allow us to
further optimize and refine the approaches in the TOPs. A strong and innovative community engagement
program, including a new MEDIC Scholars Program, will help disseminated the technologies and provide training
opportunities across all career stages and promote MicroED research in institutions located in IDeA states.
MEDIC will continue its impactful work to ensure continued optimization of MicroED and dissemination of the
method. MicroED will be democratized through innovative and extensive user training and support, and work
with technology partnerships. Taken together we expect MEDIC to continue playing a pivotal role in optimization
of MicroED technologies and dissemination to bring new and important structures to light.

Public health relevance
PROJECT NARRATIVE The MicroED Imaging Center at UCLA (MEDIC) brings together experts in electron diffraction, crystallography, computational science, physics, biochemistry, and cryo-EM, to continue the optimization and refinement of the powerful method of microcrystal electron diffraction (MicroED). Through collaborations with key driving biomedical projects, and robust community outreach and training efforts, MEDIC will continue to serve as a critical focal point for the structural sciences and biomedical research. Optimized methods to facilitate structure determination of macromolecules and small molecules are critical to the advancement of structural biology, pharmaceutical research, and the broader biomedical sciences.